Investigation of therapeutic potential of exogenous ubiquitin following myocardial ischemia/reperfusion injury

Ischemic heart disease (IHD) is a leading cause of death among veterans. Myocardial infarction (MI) is
a serious outcome of IHD, and is generally attributable to the detrimental effects of myocardial
ischemia/reperfusion (I/R) injury. Cardiac inflammation and extracellular matrix deposition (scar
formation) are essential events in the cardiac remodeling post-MI. Therapeutic approaches targeting
these events may hold promise for patients with MI. This proposal investigates the therapeutic potential
of ubiquitin (UB; a small molecular weight protein typically associated with tagging proteins for
proteasomal degradation) in myocardial remodeling following myocardial ischemia and I/R injury. The
proposal is based on our novel observations that exogenous UB plays a protective role in β-
adrenergic receptor-stimulated myocardial remodeling. In human THP1 leukemia cells, CXCR4 is
identified as a receptor for extracellular UB. Our preliminary data using - i) isolated heart model of global
ischemia/reperfusion (I/R; Langendorff model); and ii) in vivo myocardial I/R injury in mice now suggest
a protective role of exogenous UB in myocardial remodeling following I/R injury. UB treatment
decreased infarct size, reduced cardiac inflammatory response and improved heart function 3 days
post-I/R. In vitro, UB treatment inhibited migration of neutrophils, and enhanced phagocytic activity of
macrophages. In adult cardiac fibroblasts, UB treatment activated ERK1/2, and increased expression
of vascular endothelial growth factor-A (VEGF-A). UB co-immunoprecipitated with CXCR4, and CXCR4
antagonism negated the effects of extracellular UB on ERK1/2 activation and VEGF-A expression. UB
treatment augmented α-smooth muscle actin (a marker for myofibroblast differentiation) expression
and collagen gel contractile activity of fibroblasts, while decreasing migration of fibroblasts into the
wound area and inhibiting FBS-stimulated cell proliferation. These observations led us to hypothesize
that exogenous UB, most likely acting via CXCR4, modulates cardiac inflammatory response and
extracellular matrix biology by affecting phenotype and/or function of neutrophils, macrophages and
fibroblasts, thereby playing a cardioprotective role in myocardial remodeling following ischemia and I/R
injury. Aim 1 will investigate, in vivo, the therapeutic potential of exogenous UB in myocardial
remodeling following myocardial ischemia and I/R injury. Aim 2 will examine, in vivo, the role of CXCR4
in modulation of cardioprotective effects of exogenous UB using CXCR4 antagonist, UB mutants and
cell type-specific CXCR4 knockout mice. Aim 3 will investigate the cellular and molecular mechanisms
by which exogenous UB affects cardiac inflammatory response and extracellular matrix biology to
coordinate post-I/R cardioprotective response. The Innovation of this project lies in the investigation
of therapeutic potential of exogenous UB in myocardial remodeling following myocardial ischemia
and I/R injury (clinically relevant model). The proposed studies investigating the role of exogenous UB
in cardiac inflammation and extracellular matrix biology may uncover novel strategies for the treatment
of IHD.

Public health relevance
Heart attack, a leading cause of death among veterans, causes damage to the heart and compromises heart function. Therapies aimed to preserve heart function have been somewhat effective, however, development of new therapeutic approaches is needed to improve the outcome of patients suffering from heart attack. Using a mouse model, this project explores the therapeutic potential of ubiquitin (a naturally occurring small molecular weight protein; found in all eukaryotic cells) following heart attack, which may lead to the development of new and cost effective strategies for the treatment of heart attack.